Regulation of protein synthesis during cellular stress

Project Summary/Abstract
Cells experience and rapidly respond to environmental stressors by modulating which mRNAs
are selected for protein synthesis. A central factor in this process is the essential heterotrimeric
translation initiation factor eIF2. eIF2 is a G-protein complex that, in its active GTP-bound form,
delivers initiator methionyl tRNA (Met-tRNAiMet) to the ribosome. During cellular stress, eIF2 is
phosphorylated on its α subunit (eIF2α-P) in a pathway known as the Integrated Stress Response
(ISR). eIF2α-P inhibits the exchange of eIF2-GDP for eIF2-GTP, causing a decrease in active
eIF2 levels and general protein synthesis. In addition, specific stress-responsive factors, including
the bZIP transcription factors ATF4 and CHOP, are translationally induced when active eIF2
levels are low. The ATF4 and CHOP mechanisms of translation control involve upstream open
reading frames (uORFs) in their mRNA 5’-leaders. Importantly, the majority of mammalian
transcripts contain uORFs, so the presence of an uORF is not sufficient for selection of an mRNA
for translation during the ISR. Rather, we and others have determined that unique combinations
of uORF features dictate how a given mRNA will be translationally regulated when active eIF2
levels are low. Additionally, while emphasis has been placed on understanding the regulatory
schemes that drive GTP and Met-tRNAiMet binding to eIF2, we lack a complete picture of eIF2
biogenesis itself. This is critical to note as the efficiency of eIF2 heterotrimer formation also
dictates the overall level of active eIF2. Furthermore, impaired eIF2 heterotrimer formation,
modulation of active eIF2 levels, and dysregulation of the ISR are implicated in multiple stress-
related diseases, including neuropathologies, diabetes, and various cancers. Our broad objective
is to understand how cells regulate protein synthesis to maintain homeostasis. We hypothesize
that a decrease in active eIF2 levels, whether driven by impaired eIF2 complex formation or
eIF2α-P, underlies gene expression programs that are specific to the ISR and determine cell fate.
We are using innovative and holistic approaches that feature -omics methodologies coupled with
biochemistry, molecular biology, and structure-function studies to address three key questions.
1) How is formation of the eIF2 complex coordinated? 2) What is an ISR translational signature,
and what are the mechanisms by which eIF2 selects or disregards mRNAs for translation? 3)
How does eIF2-mediated translational control modulate the proteome and cell signaling to
determine cell fate? Completion of the proposed studies will provide fundamental insight into the
regulation of eIF2 function and how cells modulate protein synthesis to maintain homeostasis,
laying the foundation for advancements in the diagnosis and treatment of stress-related diseases.

Public health relevance
Project Narrative This proposal focuses on how cells regulate protein synthesis to maintain homeostasis in response to environmental stress. We are specifically addressing how the formation and activity of an essential translation initiation factor, eIF2, dictate translational control schemes to restore cells to a functional, stable state. These studies will lay the foundation for advancements in the diagnosis and treatment of cellular stress-related diseases associated with dysregulated protein synthesis, including neuropathologies, diabetes, and multiple cancers.